Multiphoton Microscopy Development

Multiphoton Microscopy has become the method of choice for intravital imaging at submicron
resolution. It works by both temporally and spatially compressing very high numbers
of near infrared photons into the focus of a microscope objective. Millimolar photon
densities permit the simultaneous absorbtion of two photons by the fluorescent dye,
yielding the same excited state one would get with a single, bluer photon. This occurs
only in a privileged (high photon concentration) zone about a micron tall and 250 nm wide,
ellipsoidal in shape, known as the PSF (point spread function). Thus the tiny spot IS
the image; one must simply raster it about to get a picture.
Importantly, ALL light leaving the dye is useful. We previously developed TED ("Total Emission Detection") devices to overcome these signal limits.
We had, in previous years, tested dendrimeric oxygen probe molecules that phosphoresced. We found this slower than optimal, hard to target, and often toxic. We instead developed (first in cuvettes, now in cells) new nanosecond oxygen probes based on FRET to O2- binding proteins, and we are exploiting these first probes while reworking others for greater range and reliability as DNA-based transfections. We have targeted Mb-mCherry, for example, to mitochondria, where we can directly image oxygen levels near their biggest sinks. We have also published conditions for mild hypoxia within nuclei.
Testing of intracellular oxygen levels in differing metabolic conditions have been done, in normal and cancer cells. We have published correlative studies of oxygen consumption and NADH "redox ratio" indicators of metabolism to examine aggressive vs. passive cancer cell growth and effects on the "OXPHOS to glycolysis" switching done by neoplastic cells. This year, we used these tools to study taxol-induced damage to mitochondria, finding that this very popular chemotherapeutic agent is harmful to mitochondrial energetics and directed movement, even at very low (likely subclinical) levels.

In addition to device development, we can employ the multiphoton microscope to do FCS- Fluorescence
Correlation Spectroscopy - of labeled molecules inside living cells. With FCS, we previously watched
a few hundred transcription factors in the cell nucleus and determined their mobility (i.e. are
they free or chromatin-bound?) with cofactors. The same principle was currently applied to mobility of taxol-damaged mitochondria, using related methods called STICS and RICCS. WE find taxol damaged mitochondria are loosened from their microtubule 'railway' tracks in the cell and move in less directed ways. This may have relevance to chemotherapy-induced neuropathy.

We have focused this year on disseminating our methods to multiple collaborations, esp. myocytes and cancer cells, and refining global analyses of the images for more precise, reproducible measurements.